Commercial Fishing Safety Training in West Coast

Abstract
The National Institute for Occupational Safety & Health (NIOSH) has recognized commercial
fishing as one of the most hazardous occupations in the U.S. The objective of this project is to
reduce work-related fatalities and injuries among commercial fishermen. This will be achieved
through safety training of commercial fishermen and instructors in California, Oregon, and
Washington, new training equipment and educational resources for use by instructors teaching
marine safety to commercial fishermen, and Personal Flotation Devices provided to commercial
fishermen to directly address the highest risks of injuries and fatalities for commercial
fishermen.
Outcomes of this project will be 24 new Drill Conductor instructors, 360 new Drill Conductors,
90 young fishermen trained, 120 fishermen trained in stability, update and distribution of the
Marine Safety Instructor-Training manual and instructor resources, PFDs distributed at a low
rate to 300 fishermen who complete Drill Conductor workshops, and training equipment and
educational materials purchased.
This training proposal uses R2P to take training research on the causes of injuries and fatalities
from NIOSH and other epidemiologists, as well as casualty reports from USCG and National
Transportation Safety Board (NTSB) reports and “lessons learned” into all aspects of our
curriculum. We also use r2p derived materials on our website and educational publications we
produce and incorporate r2p into all educational materials and in instruction.
This proposal conforms to 46 U.S.C. 4502 (i) Safety Standards for commercial fishing safety
training and address FI-01 and FI-04 of the National Occupational Research Agenda for
Fishing:
1. Reduce the risk of fatal and non-fatal injuries in the commercial fishing sub-sector.
2. Reduce injuries and illness in the vulnerable worker populations in the fishing sub-
sector.

Public health relevance
Project Narrative Commercial fishing continues to have one of the highest rates of fatal injuries of any major occupation in the US, despite the fact that fatality rates have been falling for 30 years. Accessibility to the protective effects of high quality, skills based fishing safety training continues to be a barrier due to a lack of port-based, accessible fishing safety instructors. This project will enhance both the quantity, quality and availability of safety training for commercial fishermen by supporting and expanding the number of commercial fishing safety trainers in U.S. ports through AMSEA’s Coast Guard accepted instructor-training course and coordinate with other existing commercial fishing safety programs in sharing resources, coordination of training, promotion and other aspects, to provide affordable, accessible, relevant, hands on training to fishermen in California, Washington, and Oregon.